Investigating the prognostic role of intrinsic immune evasion mechanisms in HNSCC

ABSTRACT
Head and neck cancer is one of the most prevalent aggressive cancers worldwide, with the majority being
squamous cell carcinoma (SCC), or HNSCC. The well-known risk factors associated with the genesis of
HNSCC include human papillomavirus and environment factors including tobacco and alcohol use. Despite
more than two decades of research into the molecular genetics of HNSCC, there is still lack of prognostic
biomarkers that can guide current treatment and management of HNSCC patients. Previous studies and our
preliminary analysis showed that top immune-centric biomarkers had the most promising prognostic value
for HNSCC patients compared to other immunotherapy-favorable cancers such as skin and lung cancers. In
this R01 project, we propose a large-scale secondary analysis of existing transcriptomic and genetic data to
elucidate the prognostic role of intrinsic immune evasion mechanisms in head and neck cancer. The
underlying central hypothesis is that tumor-intrinsic and host-intrinsic immune signaling co-modulate the
effectiveness of existing therapies in HNSCC; and elucidation of the interaction between targeted
genomic/genetic alternations and background tumor-immune signatures via efficient statistical and machine
learning methods can lead to novel prognostic biomarkers, as well as potential therapeutic targets. To this
end, we propose three specifics aims. In the first aim, we will generate HNSCC-specific immune signatures
by integrating single-cell and bulk-tumor transcriptomic data using novel machine learning methods
developed by our team. In the second aim, we will discover and prioritize immune-related long non-coding
RNA (lncRNA) biomarkers by recalling existing transcriptome data and applying an efficient genome-wide
screening method. In the third aim, we will combine baseline germline variants with tumor immune
signatures and further examine its prognostic value in patients treated by immune checkpoint blockade
(provide by multiple institutes including Moffitt, OSU and UNC). Collectively, we propose the most extensive
study to date in HNSCC investigating under-investigated element of the genomics source for predicting
clinical and tumor immune phenotypes. The new omics data resource and resulted biomarkers, especially
the immune-related biomarkers, from our research have potential to impact upon the diagnosis and
prognosis of HNSCC patients and could guide more efficient and personalized immunotherapy selection in
the future.

Public health relevance
NARRATIVE There is a pressing and unmet need to identify prognostic biomarkers in head and neck cancer. By repurposing existing genomic data available in public databases and at Moffitt, we propose the first large-scale study investigating the potential of immune mechanistic signatures and their mediators as biomarkers in predicting patient survival outcomes in head and neck squamous cell carcinoma. Such knowledge may lead to improved identification of patient subgroups for development of novel and targeted therapies in HNSCC.